Endovascular Suturing Device for Augmentation of Endograft Fixation During Endovascular Repair of Abdominal Aortic Aneurysm to Reduce Reinterventions Due to Endograft Migration or Type 1a Endoleak

PROJECT SUMMARY
Abdominal Aortic Aneurysm (AAA) is diagnosed in over 200,000 Americans each year. Large AAAs are treated
with stented grafts using an open surgical repair (OSR) procedure or with a less invasive endovascular repair
technique (EVAR). Under current practice guidelines, 80% of patients are treated with EVAR because of the
greater peri-operative mortality associated with OSR (5%). However, current practice is being challenged by the
mounting evidence of long-term endograft durability following EVAR. Roughly 20% of EVAR patients require
reintervention at 5 years, and 30% at 10 years; 10 year mortality has been found to be worse following EVAR
compared to OSR. The cause of EVAR failure is graft migration over time. The solution is to secure the proximal
cuff (the top portion) of the endograft to the aorta immediately below the renal arteries, a solution that has been
validated by a currently marketed device. While this device has established the feasibility of EVAR endograft
anchoring, it uses a technique that has been found to be difficult to use with high failure rates. Vesteck has
developed and established the feasibility of a device that utilizes novel and proprietary technology to address
both the problem of long term EVAR durability and the problems associated with the currently marketed
endoanchoring device. Preliminary pre-clinical V&V testing of the Vesteck device was completed in 2022 to
support First-in-Human early feasibility studies. To date, 14 patients have been successfully treated without any
device-related safety events. Vesteck has developed a robust regulatory strategy targeting the U.S. market
through a series of pre-submissions with FDA’s Division of Circulatory Support, Structural and Vascular Devices,
receiving invaluable feedback. Our goal in this Direct to Phase II SBIR project is to complete activities required
to clinically validate the safety and effectiveness of the Suture-Tight Suture Delivery system to support a Class
II 510(k) premarket notification for FDA clearance. The specific aims of this project are to: 1) Conduct pre-clinical
verification and validation of device performance requirements to demonstrate that the device design and pre-
market manufacturing processes meet design requirements based on the V&V test strategy and test protocols
reviewed by FDA; 2) Demonstrate device-readiness for pre-market clinical validation by successfully obtaining
FDA approval of an Investigational Device Exemption (IDE); 3) Clinically validate device safety and
effectiveness; and 4) Develop processes to scale up device manufacturing and reduce product costs. Successful
completion of this SBIR Phase II project will be an important milestone indicating readiness for a marketing
submission to the FDA. The activities of this SBIR project are most critical to not only achieving market clearance
of a device that is safe, effective, and marketable, but also toward providing users and patients with a solution
to the problem of long-term EVAR durability.

Public health relevance
PROJECT NARRATIVE Each year, more than 200,000 people in the United States are diagnosed with abdominal aortic aneurysm (AAAs). Under current practice guidelines, the recommended treatment is endovascular aneurysm repair (EVAR); however, long-term outcomes of patients treated with EVAR have shown an unacceptably high rate of reinterventions due to endograft migration. The purpose of this research is to support development of a novel medical device that uses an endovascular technique to secure the top (proximal) neck of the endograft to the aorta, preventing migration.